The Divorce Decline and Relationship Stability: 1970-2019

Title: The Divorce Decline and Relationship Stability: 1970-2019
ABSTRACT/PROJECT SUMMARY
To assess fundamental questions such as “what is happening to the family?” in the United States, we need to
understand basic trends in family patterns. An area in which there are gaps in our knowledge—but is of deep
importance to individuals and the public—is trends in divorce and relationship stability. Issues of data quality,
the rise of cohabitation and the increasing selectivity of marriage, changes in population composition, and
diverging patterns by education and race/ethnicity complicate analyses of trends. The primary goal of this
research is to determine the extent to which the observed decline of divorce in the U.S. since the late
1970s should be interpreted as evidence of increased coresidential relationship stability. To address
this question, we combine two data sets that contain information on marriage and cohabitation entry and
dissolution that together avoid many of the pitfalls of prior data sources; estimate the extent to which changes
in selection into marriage and population composition explain trends; incorporate the often overlooked older-
population who now constitute important contributors to dissolution rates; and examine differentials by
education, race/ethnicity, and parenthood status.
Given that even recent research on divorce and marital dissolution finds, on average, negative associations
with adult and child well-being (e.g., Kim, 2011; Leopold, 2018), should the decline in divorce rates since the
late 1970s be interpreted as a cause for optimism about the stability of committed romantic relationships in the
U.S.? There are several reasons to doubt this interpretation. First, recent research has raised the possibility
that the divorce decline is an artifact of data problems and changes in population composition (Kennedy &
Ruggles, 2014) rather than a true increase in relationship stability. Second, the divorce rate does not capture
other kinds of relationship dissolution such as marital separation and cohabitation breakup. Thus, an
examination of divorce rates alone underestimates the dissolution of coresidential unions. Third, there are
sizeable differences in marital dissolution by education, race/ethnicity, and parenthood status. Marital
dissolution has only declined for women with a college degree and not for those with less education (Martin,
2006), and trends also differ by race/ethnicity (Raley et al., 2015). But combined union dissolution trends for
coresidential unions by education, race/ethnicity, and parenthood status have not been estimated to our
knowledge.
Our research addresses each of these issues. The results will allow us to assess whether the decline in
divorce observed in past studies can be interpreted as evidence of a decline in relationship instability, and if so,
the extent to which this is shared across key population subgroups in the U.S.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT/PROJECT NARRATIVE Divorce and relationship dissolution are associated with negative mental, physical, and financial consequences, on average, for adults and children alike. As such, it is a key indicator of population health and well-being and is of keen personal interest to individuals and the public. Nevertheless, we currently have an inadequate scientific understanding of basic trends and patterns of divorce and relationship dissolution with which to assess time trends in relationship stability.